ESTROGEN AND GH EFFECT ON PROTEIN SYNTHESIS AND BONE DEPOSITION IN TURNER SYNDR

The hypothesis to be tested is that estrogen and growth hormone are synergistic in stimulating both whole body protein synthesis and bone deposition in Turner syndrome girls and adults.